Transcriptomics and Repertoire Profiling

CORE C: PROJECT SUMMARY
The main goal of this core is to establish and provide robust experimental procedures for profiling the
transcriptomes and immune repertoires of tissue-resident lymphocytes. We will employ innovative methods for
whole transcriptome and immune repertoire profiling in bulk populations, epigenomics, and single cell analysis.
For low-input, population-level RNA-Seq we will use our recently established protocol for high-sensitivity mRNA
capture and library construction. We will also provide bulk ATAC-Seq for measuring open chromatin. For single-
cell RNA-Seq, we will deploy our microfluidic system for large-scale single cell capture and cDNA barcoding as
well as a highly efficient plate-based method for whole transcriptome amplification. Finally, for dissecting the
clonal architecture of tissue-resident T and B cells, we will provide cutting-edge methods for T cell receptor and
antibody repertoire profiling.